Elucidating the lineage dynamics of optimal human CD8 T cell responses to SARS-CoV-2 and how CD8 T cell homeostasis is altered in Long COVID

Project Summary/Abstract
CD8 T cells are critical to the adaptive immune response to viral pathogens. When neutralizing antibodies are
insufficient to prevent viral infection outright, virus-specific memory CD8 T cells can rapidly kill infected cells and
limit the severity of infection. This has recently been identified as a potentially key mechanism by which COVID-
19 disease severity is reduced in vaccinated individuals. Memory CD8 T cells are functionally heterogeneous
within and between individuals, with some cells more capable of effectively responding during viral infection. In
the worst cases, dysfunctional CD8 T cell responses or ongoing responses to chronic viral infections could cause
persistent and debilitating symptoms, as may be the case in Long COVID. Our understanding of the dynamics
of human CD8 T cell differentiation remains incomplete, including why individuals generate functionally different
responses to an identical antigen. Developing effective vaccines will require an understanding of shared
molecular programs that can lead to potent effector responses across a range of individual immune landscapes
and CD8 T cell identities. Two key gaps in knowledge impair our ability to fully leverage the potential of T cells
in vaccines. First, little is known about the lineages that produce functionally distinct T cells in humans and what
factors promote different lineages. Second, it is unclear which CD8 T cell states retain the greatest capacity to
mount a potent effector response to combat infection. Therefore, there is an urgent need to define human
memory CD8 T cell differentiation trajectories, how they impact future responses to viral pathogens, and how
they may be dysregulated in cases where symptoms fail to resolve, such as Long COVID. We will address this
need by testing three working hypotheses: first, that T cell clones differentiate down lineages with distinct
functional capacities; second, that epigenetic features leave some lineages poised to mount more potent
responses; and third, that the immune landscape influences CD8 T cell differentiation and functionality, with
multiple classes of immune dysregulation driving Long COVID pathology. In Aims 1-2, we will use custom HLA-
I/peptide tetramers to sort rare Spike-specific CD8 T cells from 5 individuals at each of a longitudinal series of
memory and acute responding time points. We will then perform two cutting-edge single-cell sequencing
approaches that use T cell receptor and mitochondrial variant sequences to define T cell clones and track the
differentiation of these clones over time while assessing cell states by mRNA expression, protein expression,
and chromatin accessibility. Aim 3 will use a systems immunology approach in healthy vaccinees and Long
COVID patients to identify features of the immune landscape that correlate with optimal, sub-optimal, and
dysregulated CD8 T cell responses. Collectively, these studies will evaluate multiple possible causes of Long
COVID and will define the CD8 T cell differentiation lineages that produce optimal responses, providing a
blueprint for improved vaccines to reduce severe disease caused by SARS-CoV-2, Influenza, and other viruses.

Public health relevance
Project Narrative Memory CD8 T cells are generated in response to infection or vaccination and form a critical component of antiviral immunity, rapidly responding to subsequent infections by killing virus-infected cells. These memory CD8 T cells are functionally diverse, with some better-suited than others to respond during infection, but little is known about how and why T cells develop to be more or less functional. This research will use cutting-edge techniques to track the development of CD8 T cells that recognize SARS-CoV-2, providing blueprints to design vaccines that provoke more effective responses and shedding light on multiple possible underlying causes of Long COVID.